RUUTEs: Summer Undergraduate Research Experience (SURE) for Minorities

PROJECT SUMMARY
While significant educational barriers exist for minority, disadvantaged, and underrepresented groups it has been
shown that undergraduate research programs targeting these individuals increases both enrollment in graduate
programs and the number of individuals pursuing careers in the sciences. Therefore, developing undergraduate
research programs for minority, disadvantaged, and underrepresented student groups will be vital for increasing
their participation in health science graduate programs and career in the biomedical sciences. Groups nationally
underrepresented, as defined by the NIH, include racial and ethnic groups but also individuals from
disadvantaged background (rural, low-income or medically underserved area). Indeed, many rural areas across
the US face unique health and educational challenges and Utah is not immune from these. Rural residents are
more likely to die from health issues like cardiovascular disease, chronic lung disease, and stroke and fare poorly
across many social determinants of health compared to urban populations. In addition, students from rural areas
often lack educational resources including access to high-speed internet, AP coursework, or extracurricular
opportunities. They also struggle with reduced exposure to career pathways and appropriate role models.
Indeed, Utah’s rural students have lower college entrance exam scores and are less likely to enter college. With
these unique challenges in mind the Rural and Underserved Utah Training Experience (RUUTE) & Regional
Affairs program was established in 2018
at the University of Utah. RUUTE was developed as a concerted effort
to extend the University of Utah’s Health Sciences resources to rural and underserved communities throughout
the Intermountain West and to create unique opportunities for health science education and professional
development. The RUUTE office has expanded rapidly over the past 4 years (from 1 program coordinator in
2018 to 10 faculty and staff members), and continues to develop new programs each year. One of the newest
RUUTE initiatives was the development of a Summer Undergraduate Research Experience (SURE), piloted
in the summer of 2021. to provide a high quality 10-week mentored research opportunity for undergraduates
from rural areas in the Intermountain West. The SURE program has an overarching goal to provide students with
academic, research, and professional development experiences that will make them competitive when applying
to health science programs in the NHLBI mission areas. To accomplish this, the current proposal aims to: 1)
Develop a 10-week intensive summer research program focused on heart, lung, blood, and sleep-specific health
concerns for students from minority, disadvantaged, and underrepresented backgrounds from the Intermountain
West; 2) Develop a concurrent 10-week education series and professional development opportunities to
supplement the research experience; 3) Facilitate effective networking and mentoring opportunities for students
to ensure retention of individuals;
and 4) Determine the efficacy of the SURE program by tracking participants
and through both mentor and mentee feedback.

Public health relevance
PROJECT NARRATIVE This application seeks to fund undergraduates from minority, disadvantaged, and underrepresented backgrounds from the Intermountain West to participate in a 10-week summer research experience, studying heart, lung, or blood health, and a concurrent education and career development series at the University of Utah.